1H MRS IN HUMAN BRAIN AT ULTRA HIGH FIELD (94 TESLA)

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. The goal of this project is to explore the potential of high magnetic fields to measure "neurochemical profiles" in the brain with higher precision and accuracy and/or with improved spatial and temporal resolution